SAMHD1-mediated regulation of innate immunity during SARS-CoV-2 infection

Project Summary
The COVID-19 pandemic caused by severe acute respiratory syndrome-related coronavirus 2 (SARS-CoV-2)
remains a threat to public health, particularly in aging populations. The top priority for COVID-19 research is to
improve fundamental knowledge of SARS-CoV-2 and viral pathogenesis, including studies to characterize the
virus and to understand the host immunity. Our proposed study aims to better understand the molecular
mechanisms underlying SARS-CoV-2 infection and innate immune regulation, which is important for controlling
COVID-19 and potential future threats of other emerging coronaviruses.
Sterile alpha motif (SAM) and HD-domain containing protein 1 (SAMHD1) is the unique mammalian dNTP
hydrolase (dNTPase) that also regulates innate and adaptive immunity in hosts. Importantly, SAMHD1
phosphorylation negatively regulates its dNTPase activity and antiviral function. We found that SAMHD1
negatively regulates antiviral innate immune responses and inflammation through interacting with various key
proteins in innate immune signaling in macrophages. SAMHD1 transcript is upregulated in SARS-CoV-2 infected
primary human bronchial epithelial cells. Our preliminary data showed that SARS-CoV-2 infection of human lung
epithelial cell lines or primary human airway epithelial (HAE) cultures significantly upregulated SAMHD1
phosphorylation. However, the function of SAMHD1 in regulating SARS-CoV-2 replication and innate immunity
remains unclear. Our hypothesis is that SARS-CoV-2 infection increases inflammation in lung and airway
epithelial cells by upregulating phosphorylation of SAMHD1, thereby reducing SAMHD1-mediated anti-
inflammation effects.
Our established primary HAE cultures provided a physiologically relevant in vitro model to study SARS-CoV-2
infection and cellular responses. We will also use an established mouse model of SARS-CoV-2 infection as a
complementary in vivo approach in our studies. We designed two specific aims to test our hypothesis: Aim 1.
To examine the role of SAMHD1 in SARS-CoV-2-induced inflammation of primary HAE cultures and SAMHD1-
knockout mice; and Aim 2. To investigate the mechanisms of SARS-CoV-2-upregulated phosphorylation of
human SAMHD1. Accomplishing our multidisciplinary studies will help define the mechanisms by which
SAMHD1 regulates SARS-CoV-2 replication, inflammation, and antiviral innate immunity.

Public health relevance
Project Narrative Further studies of the detailed mechanisms underlying SARS-CoV-2 infection, innate immunity, and inflammation can help control potential future threats of emerging coronaviruses. We will investigate the role of the host protein SAMHD1 in regulating SARS-CoV-2 infection and innate immune responses using primary human airway epithelial cells and an established mouse model. These functional studies will enhance our understanding of the regulatory mechanisms of SARS- CoV-2 replication and antiviral immunity.